Antibodies as Drugs: The Art in Antibody Engineering

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Antibodies as Drugs: The Art in Antibody
Engineering, organized by Drs. Laura Walker and Paul W. H. I. Parren. The conference will be held in
Breckenridge, Colorado from May 5-8, 2024.
Antibodies have become the most successful and versatile class of biological drugs with well over 100
therapeutic antibodies approved for human use. Antibody engineering for optimized and novel functionalities is
providing unprecedented opportunities in our quest to develop innovative treatments for a wide variety of
diseases. In recent years, engineered antibody formats have matured from research to clinical stage molecules
with engineered antibodies currently representing about 40% of the 1,000+ antibodies in clinical development.
Therefore, this Keystone Symposia conference will review the translation of fundamental insights in both
antibody and pathological mechanisms into next generation therapeutics and will discuss the opportunities and
challenges ahead.

Public health relevance
PROJECT NARRATIVE Antibodies carry an enormous potential in the treatment of human disease, across ages, genders, races, and geographic locations. For example, in cancer, effective antibody therapies are evolving rapidly, providing opportunities for specific targeting of the broad range of malignancies in different disease stages; in infectious diseases, particularly emerging infectious diseases, investigators can rapidly identify therapeutic antibodies for lifesaving treatment or prophylaxis. This Keystone Symposia conference aims to provide the platform for sharing and integration of knowledge for experts and trainees alike to learn about the newest developments in antibody engineering that will be applied to prevent, treat and cure important human diseases.